Impact of nuclear envelope protein degradation on neutrophil lipid content and migration

Project Summary & Abstract
Neutrophils are the front-line defenders in innate immunity and are the most abundant circulating immune
cells in the human body. Unfortunately, neutrophils are also major players in perpetuating autoinflammatory
conditions. Neutrophils possess remarkable nuclear deformability, a necessary requisite for their migration from
blood vessels through micrometer sized intercellular spaces towards sites of inflammation. The overarching goal
of this proposal is to design new approaches to control neutrophil migration by manipulating nuclear
deformability.
Preliminary work has shown 69 differentially regulated nuclear envelope genes associated with neutrophil
differentiation. Many of these are associated with the nuclear lamina and lipid homeostasis proteins. This
proposal aims to use a nanobody-based protein degradation system developed by the Dassama lab, called
NanoBridge, to selectively degrade these differentially produced proteins. It proposes to use a combination of
microscopy and lipidomics to assess the impact of target degradation on nuclear lipid composition and how lipid
composition influences neutrophil nuclear deformability.
Novel aspects of this proposal include 1) development of a system for the targeted degradation of nuclear
envelope proteins, 2) assessment of lipid content in the neutrophil nucleus following targeted degradation of
upregulated lipid homeostasis proteins, 3) determination of neutrophil morphology and migration following
targeted degradation of understudied nuclear envelope proteins and 4) development of a system to modulate
neutrophil migration via manipulation of its nuclear deformability by targeted protein degradation.
The project goals will allow me to develop a well-rounded skillset in cell biology and targeted protein
degradation. I will further have an opportunity to gain experience in lipidomics technology. These skills will
combine with my pre-existing experience in natural product biosynthesis from my PhD work to give me a well-
rounded background that will facilitate my independent research career.

Public health relevance
Project Narrative Over-recruitment of neutrophils to sites of inflammation is a major driver of chronic inflammatory conditions and the modulation of neutrophils such that they do not reach sites of chronic inflammation is a promising approach to ameliorating autoinflammation. The ability of neutrophils to migrate through micron-scale pores on their way to sites of inflammation is dependent on their unique deformable nuclei. The project herein proposes to degrade upregulated nuclear envelope proteins in neutrophils, particularly those involved in lipid homeostasis, using targeted protein degradation technology in order to control neutrophil migration.